Genetic factors controlling the intensity of social behavior

PROJECT SUMMARY
The overarching goal of the Asahina lab is to understand the neurogenetic mechanisms by which animals ad-
just tactics during social behaviors in a context-dependent manner. To this end, they study agonistic interac-
tions between Drosophila melanogaster fruit flies. Flies choose between different types and intensities of social
behaviors based on both internal and external conditions (e.g., feeding status, mating status, outcomes of pre-
vious interactions). Powerful tools for manipulating gene and neuronal function in Drosophila with high preci-
sion provides a unique platform for understanding the neurogenetic mechanisms underlying this rich behavioral
flexibility. One major finding from the Asahina lab during the past 4 years is that a specific subset of octopamin-
ergic neurons suppress aggression, and that the transcriptional regulator nervy controls the expression of
genes necessary for these neurons to function as an aggression “brake”. They also characterized the genetic
origins of the functional differences between three male-specific aggression-promoting neurons. With the ability
to genetically control previously characterized aggression-promoting neurons and their development of novel
computational methodologies for characterizing agonistic interactions at fine resolution, goals of the Asahina
lab over the next five years are to: 1) elucidate how animals establish dominant-submissive hierarchies based
on experience, and 2) characterize the neuronal and genetic mechanisms by which deficits in specific nutrients
modulate behavioral tactics during competition for food. The first goal will be pursued by building upon their
recent finding that the dominant-submissive relationship can override experimental activation of aggression-
promoting neurons. They will test the prediction that experience-dependent modulation of aggressive behav-
iors is implemented by an uncharacterized neuronal or molecular mechanism. The second goal is inspired by
their finding that amino-acid deprivation dramatically increases aggression in both male and female flies, but
only when live yeast is present in the environment. They will elucidate how specific nutrition deficits alter the
function of aggression-controlling neuronal and genetic modules. These studies build upon strengths of the lab
in genetics and advanced behavioral quantification, plus their ingenuity in developing novel behavioral para-
digms for addressing longstanding questions in the field of animal behavior, most importantly: how do animals
strategically choose between behavioral options? Theoretical analyses have predicted that animals must have
evolved sophisticated mechanisms to integrate information and calculate costs and benefits associated with a
particular behavior during agonistic interactions. However, experimental systems to quantitatively characterize
the neural bases of these behavioral choices have remained elusive. The proposed experiments provide entry
points for solving this problem by re-defining functions of genes and neurons from the perspective of cost/ben-
efit calculations during competition. Proposed research will bridge this critical gap by illuminating operational
principles by which genes and neurons control context-dependent adjustment of social behaviors.

Public health relevance
PROJECT NARRATIVE Social interactions between animals and between humans can be explained quite well when the costs and benefits of specific actions are taken into consideration, but the genetic and neuronal mechanisms driving these types of context-dependent behavioral choices remain poorly characterized. Using the Drosophila fruit fly, we aim to determine the genes, neurons, and neural circuits that modulate behavior in response to two conditions that affect the perceived payoff of a fight: 1) social defeat, which increases perceived risk, and 2) nutritional deficits, which increase potential benefit. Similarities between flies and humans regarding the genes involved in social behaviors make it highly likely that results from this project will provide a foundation for understanding how genetic variation, especially those associated with neuronal disorders, can influence decision-making processes during human interactions.